Artificial Intelligence for effective communication to promote vaping cessation on social media

PROJECT SUMMARY
The National Youth Tobacco Survey showed the prevalence of e-cigarette use among high school students has
skyrocketed from 12% in 2017 to 28% in 2019 and remains high at 14.1% in 2022. While different regulatory
policies (such as the FDA e-cigarette flavor enforcement and Tobacco 21) are currently in place trying to alleviate
this vaping epidemic among youth and young adults, there is an urgent need to effectively communicate with the
public about the risks of e-cigarette use and nicotine addiction. However, how to engage the public with the e-
cigarette prevention messages is particularly challenging. Social media platforms such as Twitter/X, Instagram,
TikTok, and YouTube are very popular in the United States, especially among youth and young adults. Previous
studies have found that social media platforms are widely used to promote e-cigarette products by vape shops
and companies but are under-used by public health authorities for educating the community about the health
risks of e-cigarette use. Social media marketing of e-cigarettes as healthier alternatives to conventional
cigarettes resulted in the common perception among youth that vaping is a harmless activity. Social media
exposure to e-cigarette-related content could affect e-cigarette use (vaping) behavior, with vaping promotion
content leading to more vaping and vaping prevention content leading to reduced vaping. Therefore, social media
provides a rich and natural data resource about vaping-related messages in different formats (text, image, and
video). The purpose of the proposed study is to identify key features of e-cigarette-related social media
(Twitter/X, Instagram, TikTok, and YouTube) posts (especially vaping prevention posts) associated with high
social media user engagement (such as the number of likes) by applying advanced artificial intelligence and
statistical modeling techniques, and further validate them using the combination of an online survey study and a
semi-structured interview study. To achieve our goal, we will characterize key features of Twitter/X posts (tweets)
related to e-cigarettes associated with high social media user engagement, such as the number of retweets and
favorites, using natural language processing, machine learning, and statistical modeling techniques (Aim 1). We
will characterize key features of e-cigarette-related Instagram posts associated with high social media user
engagement through deep-learning algorithms and statistical models (Aim 2). We will characterize key features
of e-cigarette-related TikTok and YouTube videos with high social media user engagement using artificial
intelligence techniques (Aim 3). We will validate the key features selected from social media posts through a
cross-sectional anonymous online survey study and a semi-structured interview study (Aim 4). Results from the
proposed study will provide valuable guidance in designing effective vaping prevention messages for future
public health campaigns to help with the effective communication of risks associated with e-cigarette use, which
will help prevent the initiation and counter-uptake of e-cigarettes by youth and young adults.

Public health relevance
PROJECT NARRATIVE Title: Artificial Intelligence for effective communication to promote vaping cessation on social media The proposed study will identify key features of e-cigarette-related social media (Twitter/X, Instagram, TikTok, and YouTube) posts associated with high user engagement (such as the number of likes) by leveraging cutting- edge artificial intelligence, including but not limited to natural language processing techniques and deep learning models, along with advanced statistical modeling techniques. Furthermore, we will conduct cross-sectional anonymous online surveys and semi-structured interview studies to verify the key features contributing to high user engagement and, more importantly, identify features targeting specific populations. The identified key features will be valuable for designing multimedia messages (text, image, and video) that effectively promote vaping cessation, especially among youth, young adults, and other disadvantaged groups.